Preclinical development of a Nipah Virus inhibitor

Project Summary
SARS-CoV-2 has led to an increased urgency to develop treatments for additional emerging viruses and
potentially provide broader spectrum antivirals in order to anticipate pandemic viruses. Nipah virus (NiV) is a
bat-borne pathogen (family Paramyxoviridae) that results in acute and often fatal (recent outbreaks in India have
demonstrated case fatality ~70%) respiratory and neurological disease for which there is currently no FDA
approved treatment. There have been very few small molecule antivirals that have demonstrated activity against
NiV either in vitro or in vivo. These include favipiravir (EC90 15.87- 123.8 µM) which resulted in survival in the
hamster model and remdesivir (EC90 50-100 nM) when dosed daily by the intravenous (IV) route in the African
green monkey (AGM) model resulting in their survival. We recently identified the antiviral activity of pyronaridine
(EC50 = 65.57 nM and CC50 3.65 µM) for NiV (Malaysia strain, Patent No. 17/092,058). We have also shown that
pyronaridine has efficacy against Ebola in vitro and efficacy in vivo in mice and guinea pig. Additionally,
pyronaridine has demonstrated promising activity in vitro against Marburg virus and in vivo efficacy against
SARS-CoV-2 in mice. We have recently shown that pyronaridine is lysosomotropic and binds to the Ebola
glycoprotein as well as decreases the inflammatory cytokine storm in mice induced by SARS-CoV-2. We now
propose to assess the oral maximum tolerated dose and pharmacokinetics prior to performing efficacy studies
in the hamster model of NiV. If we are successful in demonstrating in vivo efficacy, we will file an orphan drug
designation and a preIND with the FDA. If we demonstrate statistically significant efficacy in Phase I we will then
perform efficacy testing in Phase II using the African Green Monkey model for NiV, perform IND enabling
toxicology studies and manufacture GMP grade pyronaridine tertraphosphate. Our ultimate aim is to bring a
treatment to market for NiV which can be stockpiled by the USA and other countries in preparation for future
outbreaks.

Public health relevance
Project Narrative We have recently identified pyronaridine as a potent inhibitor of Nipah and several other viruses such as Ebola, Marburg and SARS-CoV-2. We now propose generating maximum tolerated dose (MTD) and pharmacokinetics (PK) data in hamster. This will be followed by efficacy studies in the Nipah virus infected hamster model. The successful demonstration of in vivo efficacy in hamster will be followed by orphan drug designation and preIND filing and then set the stage for Phase II in which we will generate MTD, PK and non-human primate testing.